Core A: Administrative Core

ABSTRACT - Administrative Core
The Administrative Core (Admin Core) will serve to coordinate, direct, and integrate the Program’s operations,
facilitate synergy, and provide the infrastructure and oversight required to achieve the Program’s key scientific
goal of identifying the determinants of HIV broadly neutralizing antibody precursors in infant rhesus macaques.
The successful implementation and completion of this Program and its scientific goals will require a highly
efficient and responsive Admin Core. The Admin Core will be essential for the success of the Program because
it will provide 1) management of scientific projects and goals through coordination, relevant resources allocation,
and efficient data sharing and reporting; 2) coordination of financial management through close communication
and oversight; and 3) documentation of compliance, and thereby reduce the administrative burden of the
individual Program components, while guaranteeing efficiency and synergy across all Projects and Cores.
In addition, the Admin Core, with the guidance of the External Advisory Board (EAB) and NIH Program, will
provide scientific and managerial oversight over the Program’s activities to ensure that steady progress is made
towards scientific milestones. Specifically, Aim 1 of the Admin Core will provide overall coordination,
communications and data management with dedicated personnel to ensure seamless collaboration and scientific
progress and integrity. Aim 2 will ensure timely financial accounting and regulatory oversight to ensure
compliance with institutional, federal, and international guidelines.
By successfully completing its Aims, this Admin Core will ensure a unified research effort and support for the
Program’s overall goal to identify the early determinants of broadly neutralizing antibody precursor induction in
infant rhesus macaques. The Admin Core will guarantee efficient and coordinated conduct of all research
activities and ensure high relevance of research goals as the field evolves to achieve the Program goal of
optimizing HIV vaccine design for the induction of broadly neutralizing antibodies.